ELECTRONIC TABLES FOR STATISTICIANS

The overall goal is to provide a microcomputer package of statistical tables and functions for all the widely used parametric and nonparametric distributions. A friendly yet powerful user interface, permitting table-look-up, hypothesis testing, interval estimation, random number generation, data transformation, and tabular or graphical display, will form an integral part of the package. Such a package would be most convenient for biomedical or public health scientists and other research workers who currently use printed tables for making inferences from their data. Proven and published algorithms will be used for generating the parametric distributions. Scope for methodological innovation exists mainly for the nonparametric distributions and the user interface. Highly efficient network algorithms, developed and published by the principal investigator and co-investigator, will be used to generate the non-parametric distributions. This will ensure rapid computation and compact storage of these distributions despite the relatively limited computing resources available on the earlier generation microcomputers. Both a form-fill-Ln and a spreadsheet interface will be provided catering respectively to users with either well structured or flexible requirements. The Phase I prototype will provide the normal, student-t, binomial, and Wilcoxon rank sum distributions. It will be delivered on a 360 Kbyte, 5.25 inch, MS-DCS floppy diskette. Phase II will extend the package to numerous other distributions and to other operating systems.